USE OF RACE, ETHNICITY, AND ANCESTRY AS POPULATIONS DESCRIPTORS IN GENOMICS RESEARCH

This contract is for National Academy of Sciences to help organize meetings for NIH on the studies “Use of Race, Ethnicity, and Ancestry as Population Descriptors in Genomics Research? The Period of Performances is from 2021 September to 2023 June. The NAS (National Academy of Sciences) and NIH to establish a schedule of bi-monthly teleconferences. This contract is supported by multiple ICs, the other NIH institutes are NIA, NIDA, NIDDK, NHLBI and NHGRI.